The role of the TET-dependent DNA demethylation pathway in photoreceptor development and pathology

Project Summary
Retinitis pigmentosa (RP) and related inherited photoreceptor dystrophies are characterized by progressive
photoreceptor loss, resulting in poor vision or even blindness. While these disorders are caused by the
mutations of various genes, mutations in RHO, USH2A, PRPH2, RP1, CNGB1, EYS, PDE6A, PDE6G,
PDE6C, PDE6H, GNAT1, and NR2E3 account for a substantial number of cases. We recently performed a
genome-wide DNA methylation analysis of human and murine fetal retinas (which mostly contain retinal
progenitor cells [RPCs]), postnatal murine RPCs, and mature photoreceptors. We discovered that the
promoters of all of the genes above were highly methylated (hypermethylated) in DNA isolated from fetal
retinas and RPCs. The methylation of these promoters was significantly reduced during RPC differentiation
into photoreceptors and accompanied by an increased expression of the corresponding genes. It is generally
accepted that DNA methylation in promoter regions silences gene expression, while DNA demethylation should
occur to allow gene expression. Unsuccessful demethylation of the promoters of the genes above during RPC
differentiation into photoreceptors may reduce or even eliminate their activity, leading to photoreceptor
dystrophies without any mutations in the genomic DNA. Thus, not only mutations in DNA but also retina-
specific epigenetic changes in the DNA may contribute to the pathogenesis of RP and related diseases,
indicating the importance of understanding the DNA demethylation pathway during photoreceptor
development. The ten–eleven translocation (TET) protein family has a vital role in DNA demethylation and
regulates eye development and neurogenesis in various species. Our data and the results of other laboratories
indicate that the TET-dependent DNA demethylation pathway controls photoreceptor development. The
objectives of this project are to gain a detailed understanding of how the TET-driven DNA demethylation
pathway specifies the differentiation of RPCs into photoreceptors, and to investigate how irregularities in its
activity lead to photoreceptor death and retinal degeneration. Using a rigorous experimental design, we will
explore this pathway in accordance to our specific aims: 1) determine whether the TET-dependent DNA
demethylation pathway acts as a “vertical” epigenetic “switch” between progenitor and photoreceptor precursor
fates in the developing retina; 2) determine whether the TET-dependent DNA demethylation pathway functions
as a “horizontal” epigenetic “switch” between rod and cone photoreceptor phenotypes; 3) determine whether
TET enzymes require transcription factors with DNA binding domains acting as TET binding partners to specify
target genes for demethylation and activation during photoreceptor development. To reach these objectives,
we will employ animal models and a wide range of biochemical, molecular, and epigenetic approaches, striving
to obtain robust and unbiased results. Upon the completion of the project, we expect the results to reveal the
role of epigenetic mechanisms in photoreceptor normal and pathological development.

Public health relevance
Project Narrative Understanding the process of photoreceptor development is crucial for revealing molecular mechanisms that cause inherited photoreceptor dystrophies as well as for proposing therapeutic approaches that aim to restore visual function via the regeneration of lost photoreceptors. While significant progress has been made in understanding the signaling cascades that regulate photoreceptor development, the role of epigenetic mechanisms in this process has been explored to a lesser degree. The objective of our study is to explore the role of the DNA demethylation pathway in photoreceptor normal and pathological development.